Short-Term Institutional Research Training Grant

PROJECT SUMMARY/ABSTRACT (Description)
Our multifaceted research training program, entering Year 40 at The University of Arizona (UA), introduces,
trains and nurtures diverse medical students in health-related biomedical research and stimulates subsequent
intensive and extensive research experiences. Building from the high level of student/faculty participation and
outstanding record of trainee productivity (presentations, publications, awards, and advanced research), we will
continue to offer a mix of 3-month experiences to 23-36 MS/year to engage in NHLBI-focused laboratory/clinical
investigations fully integrated into our longstanding Curriculum on Medical Ignorance (CMI). CMI features an
intensive Summer Institute on Medical Ignorance, year-round enrichment activities (e.g., seminars, clinical
correlations, Failure/Pondering/Ethics Rounds, career advising), and advanced extracurricular research
opportunities through a popular Research Distinction Track. Our unique Virtual Clinical Research
Center/Questionarium online platform with evolving Precision Medicine Theme (“Translating Translation”)
focuses on examples, scenarios, and steps in the translation process. CMI aims to foster attitudes and skills to
address the vast shifting world of medical ignorance [i.e., "what we know we don't know (current research), don't
know we don't know (future discovery), and think we know but don't (error)"] from molecular systems to clinical
and community medicine. Questioning, critical/creative thinking, team building, mentorship, and leadership skills
are cultivated to forge a mentoring “chain reaction” through a diverse, multilevel NIH-funded research pipeline
continuum. Overseen by an experienced multidisciplinary administrative team, students choose projects across
a spectrum of disciplines and investigations (in vivo, in vitro, in situ, in silico, molecular mechanisms, clinical
trials, populations studies, and modeling approaches) that support NHLBI mission areas, encompassing the
normal and disordered cardiovascular (CV) system, lung, blood, and sleep (cardiac contractility, development,
hypertrophy, microcirculation, endothelial biology, electrophysiology, oxygenation, heart failure, resuscitation,
CV genomics/proteomics, CV prosthetics, arterial/venous/lymphatic disease); pulmonology (asthma, cystic
fibrosis, pulmonary hypertension, organogenesis, microbiome, sleep apnea); and cell-based science/therapy;
with cross-cutting themes in data science/ bioengineering/multimodal imaging; drug/ device discovery R&D, risk
factors, health disparities; and other topics of interest to student researchers and spanning translational steps
from bench to bedside to clinical practice and population health. Based on a 40-year track record reflected in
follow-up surveys of institutional impact and participant comes, we anticipate cultivating an enlarging number of
scientific physicians who understand and contribute to the research enterprise and a growing cadre of physician-
scientist leaders to replenish the dwindling supply of translational researchers. Detailed short-term and long-term
formative/summative program/participant evaluation with database registry, individual development plans, and
career portfolios will document efficacy and promote dissemination.

Public health relevance
PROJECT NARRATIVE Based on a 40-year track record, reflected in our latest Medical Student Research Program follow-up, we will continue cultivating a large number of diverse, inquiring scientific physicians who understand and can contribute to the research enterprise (emphasizing cardiovascular, lung, sleep, and blood disorders, mechanisms, evaluation, and therapy), including a growing cadre of physician-scientist leaders to replenish the dwindling numbers of translational medical researchers. In this way, we will contribute to the concerted effort of NIH and NHLBI to build the diverse enlightened medical research teams of the future, to provide the latest in personalized care and precision medicine, and thereby to expedite the translation of scientific advances from “bench to bedside to diverse community”.